Dynamic brain representations underlying emotional experience

Project Summary
Emotions play a critical role in organizing human experience and behavior, and emotion dysregulation lies
at the heart of psychopathology and functional impairment across disorders. To measure and understand
emotion dysregulation, advances in understanding the fundamentals of how the brain generates and
represents emotional states are vitally needed. This proposal develops and validates brain models underlying
emotional states in naturalistic, narrative contexts. We combine Functional Magnetic Resonance Imaging
(fMRI), multimodal latent factor models, natural language processing, and pattern recognition techniques
to develop models of brain activity that characterize how individuals generate emotional experiences. Over
the previous project period, we have developed several technical innovations to identify dynamic
emotional states from multimodal data and how they vary moment-by-moment during fMRI scanning.
These models allow different individuals to experience and express latent emotional states at different
times, accounting for the idiosyncratic interpretations of events that are a hallmark of human emotional
responses. We elicit emotional experiences using dynamic, naturalistic movies and autobiographical
stories. In Experiment 1, we infer latent emotional states using a novel application of the Shared Response
Model (SRM), a latent factor model that integrates multiple simultaneously acquired measurement
modalities including: moment-by-moment subjective ratings inferred using an innovative collaborative
filtering approach, automatically decoded facial expressions using computer vision techniques, and
psychophysiological signals. We then use these emotion signals to identify distributed patterns of brain
activity that track distinct emotional states. In Experiment 2, we characterize how cortical-subcortical
circuits involved in appraisal–and particularly the ventromedial prefrontal cortex–generate
interpretations of unfolding events that give rise to emotional experiences. We leverage high-dimensional
semantic embeddings of participants’ appraisals as revealed by a think-aloud protocol. The resulting brain
models of specific emotion categories afford several potentially transformative advantages. Such models
can (a) provide insight into which systems are necessary and sufficient for emotion generation; (b) be
shared and tested across studies, allowing us to evaluate their generalizability across contexts; and (c)
provide targets for psychological and neurological interventions.
Together, these studies will yield generalizable models of the dynamic brain patterns underlying specific
emotional experiences. Such models could transform the study of emotion by providing ways of
capturing the moment-by-moment dynamics of emotional states, and clinical research by allowing
investigators to test effects of psychological interventions on brain targets related to specific emotions.

Public health relevance
Project narrative Emotions are important for virtually every aspect of health and disease, but we do not yet have ways of measuring brain states related to specific emotions, and how these brain states are impacted by contextual factors. This project builds on recent breakthroughs in measuring human brain activity using pattern recognition, and uses these tools to define and validate emotional brain states in ways that can aid in the diagnosis, prevention and treatment of multiple brain disorders.